Synaptic mechanisms of auditory information processing

PROJECT SUMMARY
At chemical synapses, the presynaptic action potential triggers vesicle fusion and neurotransmitter release.
Although action potential-driven high Ca2+ elevation is required to rapidly trigger exocytosis, the resting level of
Ca2+ can modulate release probability via vesicle recruitment, priming and sensitization. Moreover, subthreshold
depolarizations can spread from the dendrites and soma into the axon terminals and depolarizations of
presynaptic resting membrane potential largely increase the probability of neurotransmitter release and the
strength of neurotransmission. Thus, synaptic transmission relies on a hybrid between analog changes in resting
membrane potential and digital action potential signaling, called Analog-Digital synaptic transmission. The
voltage-gated Ca2+ channels that mediate action potential-triggered neurotransmitter release have been
extensively studied in various neurons. However, the ion channels that determine the resting Ca2+ level and
mediate depolarization-induced elevation of terminal Ca2+ are largely unknown. Reasons for this gap in our
understanding include the small size of conventional synapses, extremely small Ca2+ conductances at resting
and subthreshold membrane potentials, and lack of specific pharmacological tools to dissect each conductance.
The mouse calyx of Held is a giant glutamatergic synapse in the auditory brainstem that permits direct pre- and
post-synaptic recordings, allowing us to directly study presynaptic Ca2+-permeable ion channels. In this renewal
application, we extend our previous studies on presynaptic Na+ control of vesicle recycling and loading to
characterize the Ca2+-permeable ion channels that control resting Ca2+ level and mediate depolarization-induced
Ca2+ elevations, and to study how hearing loss affects the channel function and synaptic transmission. This work
will establish a new fundamental role of resting and subthreshold Ca2+ to link activity and synaptic function under
physiological and pathological conditions.

Public health relevance
PROJECT NARRATIVE Growing evidence shows that noise exposure and hearing loss induce profound changes in the central auditory system from brainstem to cortex and that dysfunction of ion channels, termed channelopathies, has been linked to many neurological disorders, including deafness and tinnitus. This project aims to study calcium permeable ion channels and their synaptic function, and how hearing loss affects these ion channels and synaptic properties. The research proposed here will establish a new view of the role of presynaptic calcium permeable channels in synaptic function and their role after injury, providing the basic groundwork for future strategies for the treatment of channelopathies and hearing disorders.